Testing Substrate-Flux Therapies for Glycosylation Disorders using Zebrafish

DESCRIPTION (provided by applicant): For two years, four investigators will each hire a new full-time employee to identify and validate a novel therapeutic strategy for a group of rare inherited metabolic disorders, the Congenital Disorders of Glycosylation-Type I (CDG-I). These disorders result in underglycosylation of proteins and associated multisystem pathologies, morbidity, and mortality are common since the vast majority of CDG-I patients cannot be treated. Currently, 13 Type-I CDGs are clinically and genetically defined. Most have deficiencies in transferases and substrates necessary to synthesize the precursor of N-linked glycoproteins, glucose3mannose9GlcNAc2-P-P-dolichol, also known as "lipid-linked oligosaccharide" or "LLO". These deficiencies result in underglycosylation of proteins and associated multi-system pathologies, morbidity, and mortality. In many CDG-I patients, the primary defect impairs mannose metabolism. CDG-I patients all have hypomorphic alleles, and we propose to take advantage of the residual enzyme activities by a novel therapeutic strategy we term "substrate-flux". For example, in CDG-Ia (the most common form of CDG), we will use various chemical agents to "coax" more of the patients'own limited metabolite pool (in this case mannose- 6-phosphate) toward the defective enzyme (phosphomannomutase), divert the pool away from competing enzymes (mannose phosphate isomerase), and/or alter associated pathways (providing dolichol-P or regulating protein synthesis) so that the limited substrate pool is used more effectively. Our research team has three known drugs and five experimental compounds in-hand, all of which have given promising results in preliminary cell culture experiments and are ready for animal testing. However, a severe limitation of CDG research is the absence of representative animal models. Knockout mice are embryonic lethal and although CDG-gene hypomorphic mice are just now emerging, they are not yet ready as a model to evaluate therapies. Thus, to test substrate-flux therapy immediately, we are harnessing the power and speed of zebrafish genetics to generate new vertebrate CDG-I zebrafish models with morpholino oligonucleotides (essentially a "knockdown" approach). These are being validated both pathologically and biochemically. Recent preliminary data support the successful generation of pmm2 morphant zebrafish as a model of CDG-Ia;they have an appropriate LLO defect and phenotypes recapitulating aspects of CDG patients. Positive drug results with zebrafish models will rapidly determine whether flux-altering agents affect CDG-I phenotypes, and will then be confirmed with authentic CDG-I patient cell cultures. Concurrent with these studies, the mechanisms of the agents in question will be tested directly by mannose flux experiments in both normal and CDG-I human cell cultures and zebrafish models. Efficacious compounds are confirmed by flux studies in normal mice. Screening of the next generation of flux-enhancing molecules is underway. Within two years, we will identify fluxmodifying agents and demonstrate real potential for CDG treatment. At this point the known drugs would be appropriate for off-label clinical evaluation, and the experimental drugs will then be tested in emerging mouse models of CDG-I. PUBLIC HEALTH RELEVANCE: Very few patients with "Congenital Disorders of Glycosylation" (CDG) can be successfully treated. These patients suffer multi-system pathology, morbidity, and mortality because they do not glycosylate proteins normally. Our four-investigator team will hire four scientific staff to test a new treatment strategy called "substrate-flux" therapy. Since mouse models do not yet exist we will evaluate therapy in a series of novel zebrafish CDG models that we've created.

Public health relevance
PROJECT NARRATIVE Very few patients with "Congenital Disorders of Glycosylation" (CDG) can be successfully treated. These patients suffer multi-system pathology, morbidity, and mortality because they do not glycosylate proteins normally. Our four-investigator team will hire four scientific staff to test a new treatment strategy called "substrate-flux" therapy. Since mouse models do not yet exist we will evaluate therapy in a series of novel zebrafish CDG models that we've created.